53rd Annual Meeting of the American Aging Association

Abstract.
We are requesting funds to support the 53rd Annual Meeting of the American Aging Association (AGE) that will
take place on May 11-14, 2025, in Anchorage, Alaska. The 53rd Annual AGE Meeting will be held in conjunction
with the Nathan Shock Centers of Excellence in the Basic Biology of Aging Symposium (May 11). Since its first
conference in 1971, the American Aging Association has been the only scientific society in the United States
focused solely on the biology of aging. The annual AGE meeting is one of the premier meetings in geroscience
research and serves as a critical mechanism by which AGE advances its mission to promote biomedical aging
studies that target increasing the functional lifespan of humans, to keep the public informed on these activities,
to increase knowledge of geroscience among health care professionals, and to foster the scientific and
professional career development of AGE trainees and scientific members. The primary goal of the conference is
to convene senior and junior scientists in a forum where the latest discoveries in aging research are discussed
and debated, to highlight exciting new research in the field, and to promote the emergence of new ideas and
collaborative activities among participants. The theme for the AGE 53rd annual meeting is “New Frontiers in
Aging Research”. The invited speakers include prominent established scientists, early career investigators, and
trainees, all of whom will be selected based on the quality and impact of their science. We have planned 10 non-
competing oral sessions that will be held along with three special lectures and a roundtable panel discussion.
Fostering the next generation of geroscientists is a primary goal of the society; therefore, one of the sessions
will be organized in its entirety by the Trainee Chapter of AGE. In addition, we have chosen to have at least one
to two speakers in each of the sessions as early career investigators or trainees selected from submitted
abstracts. Two poster sessions are planned that will not compete with oral presentations. Abstracts will be
reviewed and scored, and the top 40 poster presenters will be given the opportunity to present their posters in a
two-minute oral “poster pitch” during the regular sessions. Gender parity will be achieved, with women
representing 55% of invited and confirmed speakers. Additionally, 48% of all session speakers will be early
career researchers or trainees, and at least 20% of speakers will be from underrepresented groups. We expect
that the meeting will be held in person with a live-streamed virtual component. AGE has experience with both
fully virtual and hybrid meetings. We will adhere to established meeting guidelines, including ensuring that day
care opportunities and special needs access are provided.

Public health relevance
Project narrative The annual meeting of the American Aging Association (AGE) is one of the leading annual conferences in aging research in the US, and advances AGE’s mission of promoting biomedical research towards increasing the functional life span of humans, increasing knowledge of biogerontology among the public and among health professionals, and fostering the career development of trainees and scientific members. The goal of the annual AGE meeting is to convene senior and junior scientists to discuss the latest discoveries in aging research, highlight new directions in the field, and promote the emergence of new ideas and collaborative activities among participants. We seek funding for the 53rd annual AGE meeting, where approximately 48% of all invited session speakers will be early career investigators or trainees, more than half will be women, and we will highlight participation from underrepresented minority groups.